Aire-expressing macrophages as novel mediators of tumor immune evasion

Project Summary/Abstract
Immunotherapy has revolutionized the treatment of cancer, but many malignancies remain resistant to
these interventions. Defining novel mechanisms by which tumors evade immune responses is therefore
of critical importance. While extensive work has focused on effector and regulatory T-cell populations in
tumors and their roles in the tumor microenvironment (TME), less attention has been paid to the myeloid
antigen-presenting populations that shape these immune responses. Several studies have demonstrated
the crucial role of macrophages in shaping the TME, tumor immunity and response to immunotherapy.
However, treatments targeting them have lagged behind T-cell directed therapies like immune checkpoint
blockade (ICB) as we still lack a complete understanding of the molecular and functional diversity of the
tumor macrophage compartment.
We have previously defined novel tolerogenic populations of antigen-presenting cells outside of the
thymus characterized by expression of the Autoimmune Regulator (Aire) gene which play critical roles in
immune tolerance and homeostasis. We have demonstrated that such extrathymic Aire-expressing cells
(eTACs) are essential for the maintenance of maternal-fetal immune tolerance, and may govern
commensal-specific peripheral regulatory T cell development. In addition, we have recently discovered
that Aire expressing tumor-associated macrophages (Aire+ TAMs) are present in mouse and human
cancers. In mice, a broad range of tumors induce or recruit Aire+ TAMs. Selective ablation of this
population significantly reduces tumor growth and, strikingly, converts ICB-resistant tumors into ICB-
sensitive ones in a manner dependent on CD8 T cells. We hypothesize that Aire+ TAMs constitute novel
populations of tolerogenic innate immune cells with critical roles in tumor immune evasion, and represent
entirely new targets with broad therapeutic potential for cancer immunotherapy. Our aims are to define
the identity and role of Aire+ TAMs in tumor immune evasion across a range of murine cancer models
and human cancers, delineate the functional and mechanistic role of Aire itself in these populations, and
define the cellular and molecular mechanisms of Aire+ TAM-mediated tumor immune evasion. We
believe that defining the biology and function of these populations could present numerous therapeutic
opportunities with transformative potential in tumor immunotherapy.

Public health relevance
Project Narrative lmmunotherapy has revolutionized the treatment of cancer, but many malignancies remain resistant to these interventions; defining novel mechanisms by which tumors evade immune responses is therefore of critical importance. We have identified unique populations of tumor-associated macrophages expressing the Autoimmune Regulator (Aire) gene (Aire+ TAMs) in murine and human tumors that play key roles in tumor immune evasion, and are associated with worse clinical outcomes and ablation of these populations significantly reduces tumor growth and suppresses the growth of checkpoint-resistant tumors in mice. We propose to define the biology of these Aire+ TAMs, their roles in immune evasion across a range of tumor types, the cell-intrinsic role of Aire itself in tumor progression and immune evasion, and the key mechanisms underlying this process as novel potential targets for tumor immunotherapy.